Validation of Epigenomic Biomarkers for Thyroid Cancer Diagnostics

ABSTRACT
Thyroid cancer is less frequent but deadlier for individuals who self-identify as African American/ Black or
Latino/Hispanic in comparison to individuals who self-identify as White/European American. Thyroid cancer
mortality in individuals who self-identify as Hispanic is higher than in individuals who self-identify as
White/European American. At the same time, thyroid cancer patients who self-identify as African American/
Black are associated with worse overall survival than patients who self-identify as White/European Americans.
There are many reasons for these disparities in survival and mortality including lack of insurance, poor access
to care, and low quality of health care; however, there is emerging evidence that biology may also play a role.
In our funded R01, we aim to validate the DNA methylation panel with 373 biomarkers to improve pre-operative
early detection of thyroid cancer. This does not include genetic ancestry. To date, we have obtained 779 of
4550 thyroid biopsies from six highly diverse centers; 100 biopsies are from individuals who self-identify as
non-Hispanic White, and 49 from individuals who self-identify as African American/Black. Here we aim to
perform a comprehensive gene expression and DNA methylation analysis of thyroid nodules from individuals
who self-identify as non-Hispanic White or African American/Black and compare with individuals who self-
identify as non-Hispanic White and test for race-specific differences. The analysis will be done based on
genetic ancestry.
Our goal is to identify race-specific differences in gene expression and DNA methylation to better
understand disparities in thyroid cancer mortality and survival. We plan to accomplish our overall objective for
this project by pursuing the following specific aims:
Aim 1: Analysis of race-specific transcriptional activity in benign and malignant nodules from Hispanic
Whites, African Americans, and non-Hispanic Whites.
Aim 2: Analysis of race-specific DNA methylation in benign and malignant nodules from Hispanic Whites,
African Americans, and non-Hispanic Whites and alignment of these data with race-specific gene expression.
This proposal addresses two important cancer disparity questions: the role of gene activity, and the role of
epigenetic changes in thyroid cancer disparities, respectively. By elucidating biological mechanisms driving
thyroid cancer disparities, our study has the potential to reduce morbidity and mortality associated with thyroid
cancer disparities and promote health equity.

Public health relevance
PROJECT NARRATIVE Thyroid cancer is diagnosed less frequently but is more deadly for individuals who self-identify as African American/ Black or Latino/Hispanic in comparison to individuals who self-identify as non-Hispanic Whites. In this study, we aim to determine whether race-specific differences in gene activity and DNA methylation for African American/Black and Latino/Hispanic in comparison to non-Hispanic Whites are involved in thyroid cancer disparities.